Acquisition of GE Typhoon FLA9500 Variable Mode Imager

A diverse user-­group of 9 NIH funded investigators, within the Krieger School of Arts & Sciences, the Whiting School of Engineering at The Johns Hopkins University, and the nearby Carnegie Institution, request funds to purchase a GE Typhoon FLA9500 Variable Mode Imager to complement, and ultimately replace, an aging and heavily used Typhoon 9410, which has been the primary workhorse for the Biology department and the entire Hopkins? Homewood Campus since 2005. investigators, all well funded through the NIH, work on a host of basic cell biological/biomedical related questions including, though not limited to, regulation of transcription and DNA binding by proteins, metabolic signal transduction, DNA alkylation, membrane organization and dynamics;? DNA methylation detection;? and RNA-­ protein assembly. In the requested configuration, the FLA9500 phosophorimager will afford our disparate group of investigators a broad range of basic/advance capabilities for imaging/quantifying gel sandwiches, full-­sized agarose and polyacrylamide gels, membranes, microplates, and microarrays. A critical angst that inspires this submission pertains to the age of our present Typhoon 9410 and concerns regarding future maintenance. We have been told that GE will not guarantee maintenance beyond 2018. Consequently, given the essential nature of quantitive gel blot and storage phosphor analysis to the basic research effort of our broader scientific community;? we are seeking to address this concern with the FLA9500 variable mode imager. The new Typhoon will be conveniently located, administered, and maintained, in the Johns Hopkins' Integrated Imaging Center (IIC);? and it will be incorporated into the IIC's existing, well established recharge system to ensure recovery of funds for supplies and maintenance.

Public health relevance
The GE FLA 9500 variable mode imager will be used to study a biological, biophysical, and biochemical problems including, but not limited to: the basic biology of retro viruses; the role of chromatin remodelers in the modulation of nucleosome movement; role of metabolites in cellular signaling; understanding DNA alkylation; detection of heterogeneously methylated epialleles in biological samples; and understanding ribosome complex assembly. In the requested configuration the FLA 9500 will allow for conventional imaging of fluorescently labeled gels, multiplex analysis, and storage phosphor imaging.